COBRE: FACULTY DEVELOPMENT CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Our original goal was to recruit four new faculty to the COBRE Program. However, due to a cut in our budget by the NCRR and due to a reduction in hiring by Dartmouth Medical School due to the financial crisis, we have revised this aim to recruit two investigators.